Discriminating the contributions of CCR4 and CCR7 to thymic central tolerance

ABSTRACT
As T cells develop in the thymus, VDJ recombination generates diverse T cell receptors (TCRs) needed to
recognize the myriad pathogens encountered throughout life, but also yields TCRs that recognize self-antigens
and could thus induce autoimmunity. Central tolerance limits autoimmunity by enforcing negative selection of
thymocytes expressing TCRs with high affinity for self-antigens or diverting them to the regulatory T cell (Treg)
lineage. To undergo self-tolerance, thymocytes must enter the thymic medulla, where they encounter dendritic
cells (DCs) and medullary thymic epithelial cells (mTECs), key antigen presenting cell types that collectively
display most self-antigens. Recent data suggest that thymic DCs express proteins induced during inflammation,
while mTECs display tissue-restricted self-antigens (TRAs) expressed at steady state by differentiated cell types.
Establishing T-cell tolerance to inflammation associated self-antigens, such as cytokines, is critical for mounting
productive immune responses to pathogens, while establishing tolerance to TRAs is essential for preventing
tissue-specific autoimmunity. Our findings over the previous project period demonstrate that the chemokine
receptors CCR4 and CCR7 cooperate to promote thymocyte medullary entry and negative selection, but also
suggest a new model in which CCR4 promotes early-stage tolerance to inflammation-associated self-antigens
expressed by DCs, while CCR7 promotes late-stage tolerance to TRAs expressed by mTECs.
We recently found that CCR4 and CCR7 are sequentially expressed by and promote medullary entry and
negative selection of immature versus mature post-positive selection thymocyte subsets, respectively. In keeping
with a cooperative role in supporting thymocyte medullary entry, double deficiency in CCR4 and CCR7 more
severely impairs negative selection. However, distinct roles for these receptors in regulating central tolerance is
suggested by the finding that CCR4 and CCR7 ligands are expressed by activated thymic DCs versus mTECs,
respectively. Also, CCR4 deficiency enhances autoreactive T-cell responses to activated DCs, while CCR7
deficiency yields lymphocytic infiltrates in differentiated tissues. These findings support a new model in which
CCR4 and CCR7 promote central tolerance to inflammation-associated antigens expressed by DCs and TRAs
expressed by mTECs, respectively (Aims 1-2). Also, CCR4 is expressed by recirculating Treg, which suppress
new Treg selection, while CCR7 is expressed by and supports survival of thymic DCs that present TRAs. Thus,
CCR4 and CCR7 may promote central tolerance not only by impacting location and cellular interactions of
thymocytes, but also by altering the activity of recirculating thymic Treg and DCs (Aims 1-2). Finally, autoimmunity
in CCR4 and CCR7 deficient mice may reflect failed central and/or peripheral tolerance mechanisms of T cells
and/or Treg (Aim 3). Altogether, the proposed experiments will test key tenets and mechanisms of the model that
CCR4 and CCR7 respectively enforce thymic tolerance to inflammatory versus tissue-restricted self-antigens.

Public health relevance
PROJECT NARRATIVE To avoid autoimmunity, maturing T cells migrate into the central region of the thymus, the medulla, where they encounter heterogeneous antigen presenting cells that display a wide variety of our own proteins, such that developing T cells that are strongly autoreactive to those proteins are either induced to undergo cell death or to become regulatory T cells that can shut down autoimmune T-cell responses. Our recent published and preliminary data suggest a novel model by which the chemokine receptors CCR4 and CCR7, which are expressed by sequential stages of developing T cells, play distinct but cooperative roles in establishing broad self-tolerance to different classes of our own proteins, namely those expressed under inflammatory conditions during infections versus those expressed at steady state in differentiated tissues, respectively. Here, we will not only test whether CCR4 and CCR7 prevent autoimmunity by inducing tolerance to distinct classes of self- antigens, expressed by different antigen presenting cells in the thymus, but we will also test whether CCR4 and CCR7 impact T-cell self-tolerance by directly regulating the ability of developing T cells to enter the medulla and undergo interactions with cells that promote tolerance therein and/or by modulating the activity and homeostasis of other cells in the thymus that educate developing T cells to become self-tolerant.